Developmental Research Program

Few funding opportunities exist nationwide for pilot projects that are focused on bladder cancer (BC). Furthermore, as the only program of its kind in the country, the MD Anderson BC SPORE must reach out directly to other translational scientists who are or may become interested in BC research by fostering interinstitutional collaboration. To address these important needs, the SPORE Developmental Research Program has evolved from a structure that largely supported projects based at MD Anderson to one that seeks to establish collaborations with groups at other institutions and establish flexible and nimble processes for identifying and rapidly funding them. To this end, we propose the following Specific Aims in this renewal application: 1.To identify potentially high impact emerging translational research projects focused on urothelial cancer,preferably at other institutions; 2. To provide seed funding for these projects for 1-2 years; 3. To incorporate the most successful as full projects within the SPORE.

Public health relevance
Bladder cancer is very common and costly, yet research support for BC has lagged behind that provided for other malignancies. The primary goal of the MD Anderson BC SPORE DRP is to serve as a source of seed funding for meritorious BC projects nationwide. Secondary objectives include establishing functional collaborative networks and recruiting talented new investigators to the field.